Vision Research Training Program

We at the Stanford Department of Ophthalmology and Center for Vision and Prevention of Blindness are applying for a T32 Training Grant from the National Eye Institute to fund a the post-doctoral program designed to Integrate basic vision research and clinical ophthalmologic training. Our goals include: 1) intensive clinical oph- thalmologic exposure, especially targeting non-clinically trained investigators, to facilitate future bench-to-bedside applications of basic vision research; 2) facilitation of the transition of M.D. and M.D.-Ph.D.-trainees from clinical practice to rigorous vision research and fostering their successful application to the Career Development (K) Award, an important funding mechanism for physician-scientists; and 3) the education and training of basic and clinical investigators from diverse backgrounds in molecular, cellular, synaptic, and systems level vision research to prepare them for academic careers in clinical and basic departments. With your help, we plan to train 4 M.D., Ph.D., or M.D.-Ph.D. fellows per year. An intensive course on basic vision research and ophthalmology (Ophthalmology 302A), weekly multi-disciplinary Stanford Center for Vision and Prevention of Blindness lectures and seminars, and other vision courses and training in epidemiology and statistics will be among the educational program tailored to each trainee's background and research interest, along with an- nual opportunities to present their work, teach, write grant applications, and attend scientific meetings. Each trainee will be assigned a basic science and a clinical mentor, chosen from Stanford vision investiga- tors which collectively hold 16 ROl grants from the National Eye Institute and have published over 100 peer- reviewed publications in the last 2 years. These mentors help each trainee publish basic and clinical papers, serve as examples of rigorous scientific and clinical Investigations, and help develop a well-rounded program to inter- weave knowledge in basic areas such as developmental patterning of the eye and visual circuitry, synaptic plastic- ity and processing of the visual pathway, visual object recognition and reading, and visual-motor integration with a detailed understanding of the diagnosis and treatment of common causes of low vision and blindness and tools used to address them. An External Advisory Committee offers independent perspectives on the Program's opera- tion. RELEVANCE (See Instructions): Because our program is designed to provide each trainee with a comprehensive understanding of vision research and its applications to prevent vision loss, our trainees are poised to make significant research contributions to tackle the different causes of blindness and low vision, which affects 160 million people worldwide and costs the United States annually 35.4 billion dollars in financial burden when considering just the major adult visual disor- ders.